Racial and social contextual factors in relation to epigenome and bladder cancer outcome.

CURED PILOT Project 2 Summary
This proposal entails strengthening the efforts between Dan L Duncan Comprehensive Cancer Center
(DLDCCC) at Baylor College of Medicine (BCM) and Texas Southern University (TSU), an institution
serving underserved health disparity populations and a historically black college and university (HBCU),
to establish the Baylor-Texas Southern P20 consortium or BCM-TSU P20 Collaborative Union for Cancer
Research, Education and Disparities (CURED). BCM-TSU P20 CURED will develop the infrastructure for a
cancer research program with a specific focus on cancer health disparities (including biology, outcomes,
and access to treatment) and community engagement with a joint Cancer Research Education Program.
This collaboration builds upon complementary expertise in cancer health disparities at DLDCCC/BCM
and TSU, cancer drug discovery and pharmacokinetics at TSU, and robust patient and community-
focused outreach and engagement focused on predominantly minority populations of both institutions
with complementary expertise and allowance of shared resources and ongoing joint endeavors with
both institutions.
The proposal for BCM-TSU P20 CURED includes the Center of Excellence for Housing and Community
Development Policy Research (CEHCDPR), a U.S. Department of Housing and Urban Development Center
of Excellence, at TSU as a member of the research team. Faculty with CEHCDPR will partner with faculty
from the Department of Molecular and Cellular Biology at BCM to study the associations between the
social determinants of health (SDOH) and bladder cancer to understand the racial disparities in disease
progression, in which African Americans experience more severe outcomes than Whites. CEHCDPR will
develop a SDOH interviewer-administered survey that will include questions about socioeconomic
characteristic, smoking history, and health care access, and residential and workplace history. BCM will
administer the survey to consenting bladder cancer patients. Once BCM has completed the survey,
CEHCDPR will use Geographic Information Systems software to geolocate each patient’s historical
residential location. CEHCDPR will compile data layers from existing sources, including US Census and
US EPA, on the socioeconomic and environmental conditions of the patient’s residential neighborhoods.
Concurrently, BCM will run DNA testing of tissue samples from the patients who completed the survey.
The CEHCDPR and BCM datasets will be combined and CEHCDPR will analyze the data to evaluate the
association between the SDOH and the cancer DNA data.

Public health relevance
CURED PILOT Project 2 Narrative Recognizing the interconnection between public health and the built environment, this research—about the racial disparities in the association between bladder cancer outcomes and neighborhood socioeconomic characteristics and environmental condition—will contribute to a depth in understanding within the public health community about the ways in which housing is one of the most important social determinants of health outcomes.